Mechanisms of dopaminergic dysfunction in substance use disorder

PROJECT SUMMARY/ABSTRACT
The mesolimbic dopamine system is at the core of reinforcement learning, and its dysregulation by stimulants
is a major factor in the development of cocaine use disorder (CUD). While dopamine is often linked to valence-
based learning, emerging data - as well as preliminary data in this proposal - has indicated that dopamine
release in the NAc core is evoked by both rewarding and aversive stimuli, thus challenging the idea of bi-
directional valence coding. It is likely that dopamine release in the NAc core signifies how salient – or important
– a stimulus is independ`ent of its positive or negative emotional value (valence). Salience is a key driver of the
speed at which information is learned in an environment; thus, deficits in a system that encodes saliency would
slow many forms of learning - both drug and non-drug associated. If NAc core dopamine signals saliency,
rather than a valence-based signal, aberrations in this system could explain several CUD-associated learning
deficits. For example, deficits in salience attribution would slow learning of new contingencies while leaving
previously learned reward-seeking behaviors, such as drug seeking, intact. Indeed, individuals with CUD
exhibit deficits in fundamental behavioral functions following repeated drug exposure that extend to non-drug
associated stimuli. These deficits in fundamental behavioral functions negatively affect the lives of individuals
suffering from CUD, and the severity of these symptoms is strongly associated with disease progression and
treatment outcomes. Thus, to determine the contribution of NAc core dopamine deficits to CUD symptomology,
it is critical to first understand the role of NAc core dopamine in basic stimulus processing and learning. Next it
will be important to understand how repeated drug exposure dysregulates these basic processes to cause
these deficits. In both rodents and humans, long-term cocaine exposure leads to reduced responsiveness of
NAc dopamine at baseline and to environmental stimuli. Our overarching framework is that cocaine use
increases behavior directed towards drug-associated stimuli, in part, by weakening of the salience of non-drug
associated events. We will combine optical tools for recording and manipulating dopamine release in the NAc
core of mice during behavioral tasks that dissociate valence from behavioral action and saliency to understand
how dopamine drives learning. Next, we will conduct a series of experiments to understand how valence-based
and valence-free learning recruits dopamine release to influence behavior. Finally, we will outline how cocaine
self-administration dysregulates dopamine responses to non-drug stimuli to drive punishment resistance and
deficits in new reward learning. Together these studies will define how cocaine self-administration alters
stimulus processing to drive behaviors characteristic of CUD.

Public health relevance
PROJECT NARRATIVE Cocaine use disorder (CUD) is a devastating syndrome that significantly affects the lives of the individuals that suffer from it. At the core of CUD is dysregulated learning for drug and non-drug rewards that drives maladaptive drug seeking, drug taking in the face of negative consequences, and an overvaluation of drug- associated stimuli. The goal of this project is to define how drug-induced dysregulation in the dopamine system underlies deficits in the processing of rewarding and aversive events in the environment to drive behaviors associated with CUD.